SUDDEN DEATH IN THE YOUNG CASE REGISTRY (SDY) - DATA COORDINATING CENTER BIOSPECIMEN AND CONSENT ACTIVITIES

Fundamental gaps exist in the understanding of sudden and unexpected death in babies, children, and adolescents. Serious study is needed to learn the incidence, mechanisms, and risk factors for these deaths, to be able to identify effective ways of preventing them. To work toward this, in 2013, the National Heart, Lung, and Blood Institute (NHLBI) and the National Institute for Neurological Disorders and Stroke (NINDS) partnered with the Centers for Disease Control and Prevention (CDC) to establish the Sudden Death in the Young (SDY) Case Registry. This Registry was built on the CDC’s existing Sudden Unexpected Infant Death (SUID) Case
Registry, which uses the data entered in the National Center for Fatality Review and Prevention (NCFRP) Fatality Review Case Reporting System (NFR-CRS) as its data source.

In 2013, the NHLBI, the National Institute for Neurological Disorders and Stroke, and CDC established the SDY Case Registry. A year later, CDC entered an Inter-Departmental Delegation Authority with NHLBI to fund state/jurisdictional agencies to identify cases, compile data, review and categorize cases according to a
standardized algorithm, and collect biospecimens to be used in SDY research. Surveillance and collection of biospecimens began in nine funded jurisdictions in 2015. In 2016, a tenth jurisdiction was added. To support awardees’ needs related to training, technical assistance, and maintenance of a biorepository, NHLBI executed an Inter-Agency Agreement with the CDC; CDC then contracted with MPHI to develop and serve as the Data Coordinating Center (DCC) for the new SDY Case Registry. In 2019, an additional funding cycle began, adding three more funded jurisdictions, and National Institutes for Health (NIH) contracted directly with MPHI to serve as the DCC for support of the consent and biospecimen activities.
MPHI is the current DCC for the SUID and SDY Case Registry and houses the NFR-CRS. Additionally, MPHI has a contract with the University of Michigan for an SDY Biorepository that manages the extraction and storage of DNA samples from SDY cases. As the
current home for both the NFR-CRS and DCC, MPHI is well poised to carry out the activities of this solicitation. Also, due to its location within the same organization as NCFRP and its NFR-CRS, the DCC is well poised to continue its current work providing SDY data to NIH and SDY researchers. MPHI will provide all labor, equipment,
materials, and supplies; perform all services to accomplish the tasks described below; and work with CDC program staff to determine and prioritize activities.
Objectives for the SDY Case Registry to be addressed by this Solicitation include: 1) Describing incidence of SDY in a large population in the U.S. using population-based surveillance, 2) Compiling data from SDY cases to create a resource of information and DNA samples for research, 3) Encouraging standardized approaches to investigation, autopsy, and categorization of SDY cases, 4) Developing partnerships between local, state, and federal stakeholders toward a common goal of understanding and preventing SDY, and 5) Supporting families who have lost loved ones to SDY by providing resources on bereavement and medical evaluation of surviving family members.